GENETIC POLYMORPHISM AND HUMAN BEHAVIOR

Collect DNA samples from patients with anxiety or depressive disorders and from control subjects. Genotypes will be obtained for individuals at loci where there is either known or suspected physiological variation. Genotypes will also be obtained from other loci but when there is no known or suspected relationship to physiology these data will be used only for establishing population allele frequencies.